Summer Mentoring and Research Training in Eye and Vision Research (SMART EVR)

ABSTRACT
Blinding diseases such as age-related macular degeneration, diabetic retinopathy, and glaucoma, together with
ocular infections and dry eye disease represent a public health crisis. The impact of these diseases is
compounded by the insufficient number of skilled clinicians and investigators with high quality training and
expertise to provide care and conduct translational research. It is vital to foster a new generation of physician
researchers that possess a diverse array of knowledge and skills, including understanding basic (genetics,
molecular and cellular biology, neuroscience), patient level (clinical care, neuropsychology, fluid biomarkers,
neuroimaging, epidemiology), and cross cutting (biostatistics, ethics) research design and methods. Thus, our
proposed Summer Mentoring and Research Training in Eye and Vision Research (SMART EVR) T35 program
will grow the pipeline of medical students with research experiences inspiring new physician scientists to focus
their careers on eye and vision research and ophthalmic care. The low availability of skilled translational
physician scientists represents a threat to the national eye and vision research agenda. Therefore, in this T35
application we propose to engage MD students in hands-on research, mentoring, publishing, career
development and leadership. Through our leadership expertise in multidisciplinary translational eye and vision
research, we aim to enhance the diversity and availability of physician scientists through these three specific
aims: 1) Champion mentored career development by providing an integrated program that consists of
outstanding leadership and oversight. 2) Create a flexible and innovative curriculum that emphasizes both core
and advanced competencies in clinical, translational, and basic science 3) Maximize access to the SMART EVR
Program. Through formal check-ins and eye and vision research themed journal clubs, trainees will receive
guidance and support from the program directors. Upon the completion of the SMART EVR program, students
will be tracked through the four years of medical school to encourage their continued engagement in research
activities.

Public health relevance
NARRATIVE This Summer Mentoring and Research Training in Eye and Vision Research (SMART EVR) T35 program is anticipated to fill the gaps that exist in the availability of physician-scientists to address evolving global health challenges through research, discovery and awareness. This training program will leverage the outstanding mentoring expertise at UCI in inherited and age-related eye diseases and retinal degeneration, pharmacology of the visual cycle, ocular surface biology and pathobiology, and retinal neurobiology. Moreover, the translational emphasis of the research mentors will enable trainees to be exposed to essential discoveries that contribute to lasting and impactful changes in clinical practice.